Analysis and Prediction of Molecular Interactions

Abstract
Our research focuses on molecular recognition, with the goal of providing methods and software for solving
biomedical problems. The primary areas of interest are protein-protein interactions and the ligand binding
properties of proteins. We believe that predictive methods will be substantially improved during the next five
years due to the increasing amount of information on sequences, structures, and interactions of molecules in
the cell, and the unprecedented availability of computing power. To take advantage of these opportunities we
will integrate the use of structural templates, co-evolutionary information, and machine learning into classical
biophysical methods. Our rigid body protein docking server ClusPro, which has over 15,000 users, will be
combined with our new template based server ClusPro TBM. We also add elements of flexible docking, either
by remodeling the regions that cause steric conflicts, or by using a neural net for calculating post-minimization
energy values without performing the actual minimization. Several tools will be combined for the structural
analysis of protein interaction networks, including a novel method of constructing multi-protein complexes
based on pre-calculated tables of interaction energies between pairs of proteins. Examples of applications
include the design of PROteolysis TArgeting Chimeras (PROTACs) for modulating a target protein by
degradation, the prediction of antibody epitopes, and searching for epitope-specific antibodies. To study the
ligand binding properties of proteins we focus on binding hot spots, regions of proteins that are major
contributors to the binding free energy. Our FTMap server globally samples the surface of target proteins using
fragment sized molecular probes and provides reliable hot spot and pharmacophore information. We will
improve the scoring function using neural nets, and expand the set of probes to obtain generalized
pharmacophores that identify regions in the protein binding site with preferences for specific functional groups
and a number of bound fragments. Since this information can be used to find larger ligands, the goal is to
convert FTMap into a fragment based ligand discovery platform. We will also improve our template-based
server LigTBM, which docks small molecules to proteins, and will integrate template-based modeling with
FTMap. In a collaborative application we will analyze metabolite-protein interaction data obtained by precision
mass spectrometry in E. coli and human protein pull-down experiments. FTMap will be used to test whether a
target protein has a suitable binding hot spot, and LigTBM will place the metabolite. We are particularly
interested in finding metabolites that bind at novel allosteric regulatory sites. A related application will be to
study ensembles of structures obtained by dynamic simulations to find potential correlations between FTMap
derived binding properties at different regions of proteins, thus exploring potential allosteric communication.

Public health relevance
Narrative Our research focuses on molecular interactions, and we develop methods for protein-protein docking and the characterization of ligand binding properties of proteins. Predictive tools for these applications will be substantially improved by integrating classical biophysical approaches with sequence, structure, and interaction information on biological macromolecules, and by utilizing the unprecedented availability of computer power. The methods will be implemented as web-based servers for use by the biomedical research community.